NONTHYROIDAL SERUM MARKERS VS TSH AND THYROGLOBULIN IN THYROID SUPPRESSION

The aim of this study is to establish nonthyroidal biochemical parameters which could be used for the detection of subclinical hyperthyroidism.